Support of NCI CCR Clinical Research and Bioinformatics

This project is involved in many aspects of support for the National Cancer Institute, NCI, Center for Cancer Research, CCR. Projects which we develop and or maintain include the following: Labmatrix, a tissue research and inventory system for management for both the collection and storage of tissues, as well as data resulting from the research analysis of the tissues. CCR Protocols website for NCI and Clinical Center distribution of our clinical trials protocols. Confluence wiki to facilitate standardized documentation, collaboration and simple website development for CCR scientific staff. Confluence acts as an interface to our DB Quick technology, allowing ultra fast development of simple web based database applications. Jira issue management software is used to support the groups in the CCR which need to manage user requests StarCatcher / StarGazer for the collection and review of potential post-doctoral fellow's CVs Budget Management System is used to allocate funds to CCR principal investigators and core research groups. CCR Referrals is currently in development. It will provide a standardized way to manage potential clinical trial participants and their medical information as it pertains to being qualified to participate in CCR clinical trials. PA Tracker for the tracking of human resource packages through the approval process Video conference support for scientific presentations including CCR Grand Rounds and CCR Eminent Lecture series as well as many smaller scientific collaborations. Section 508 compliance of CCR run websites. CCR Annual Reports system is developed and maintained by the contractor DMS. Our staff work with the data every year to be able to generate all necessary reports.